Coordinating center for collaborative marmoset research

PROJECT SUMMARY/ABSTRACT
The common marmoset (Callithrix jacchus) has emerged as a critically important and tractable non-human
primate (NHP) model for neuroscience research accommodating genetic manipulation and directed breeding.
Several barriers to the adoption of marmoset models by the neuroscience community exist, including a small
census size in the United States (fewer than 2,500 animals available for research), poor communication about
resource availability, a poor understanding of the strengths and limitations of marmosets in research, and a lack
of a formal structure for coordinating the sharing of information and resources related to marmoset research.
In this application, we propose to continue operation of the Marmoset Coordinating Center (MCC) a virtual center
created to maintain a national census of research marmosets, characterize the genetics of marmoset colonies,
and facilitate transfer of marmosets for research. As the foundation for the MCC, we built an informatics
framework for coordinating marmoset research based on the LabKey data management system. This system
contains basic statistics on the marmoset populations provided by participating laboratories, making pre-
recorded, individual-level information more broadly available to the neuroscience community. Demographic and
genetic information is generated, shared and discussed among participating centers, to coordinate marmoset
colony management in line with Association of Zoos & Aquariums practice guidelines. Via the website, the MCC
oversees submission, review, approval and tracking of requests to purchase marmosets generated by federally
funded breeding programs.
In this iteration of the MCC, we will continue to develop the center by expanding the genome data available on
marmosets, and by enhancing the functionality of the MCC website. We will collect tissue from uncharacterized
animals, whole genome sequence DNA extracted from these tissues, and integrate the new genomes with our
existing genomic knowledge ebase. We will research new, easier ways to generate high-quality genome data
from marmosets. The website will be expanded to include more summary statistics on marmoset genetics at
both the individual and colony level, and to provide up-to-date information on the availability and location of newly
generated marmoset resources developed by companion programs, such as cell lines and genome editing
reagents. Together, the data and human resources of the MCC will provide an essential portal into marmoset
neuroscience research through collaboration, service agreement, or animal transfer.

Public health relevance
PROJECT NARRATIVE The common marmoset (Callithrix jacchhus) has emerged as a critically important biomedical animal model. Increased demand for marmosets in scientific research has been most acute in neuroscience, where the need to study cognition, behavior, and mental illness in primate models with new genomic editing and gene targeting methodologies has surged. This project will continue the operation of a national marmoset coordinating center, that integrates genomic and demographic data on US marmoset populations, which together provide information and access to animals for scientists in the broader neuroscience community.